Clinical Decision Support to Promote Immigrant Child Health Screening

Project Summary
The majority of non-refugee immigrant children entering the US receive limited or no screening for infectious
conditions. Delays in the diagnosis and treatment of infectious conditions in immigrant children can result in
increased adverse patient outcomes and increased spread of communicable diseases. There is publically
available, evidence-based guidance for clinicians in the form of an American Academy of Pediatrics’ (AAP)
Immigrant Child Health Toolkit. However, most clinicians have only cursory familiarity with this resource or the
needs of immigrant children.
With the expansion of electronic health records (EHR) into primary care, one of the most promising strategies
for increasing awareness of and standardizing infectious disease screening for immigrant child populations is
the use of clinical decision support (CDS). CDS that is evidence-based, developed in concordance with local
workflows, and tested by representative users is more likely to have a positive impact on patient care. CDS
developed to be shareable holds great promise for reaching populations—like immigrant children—who are
seen by a large number of geographically-dispersed health care providers, many of whom practice in safety-
net settings where resources are more limited. The process of translating evidence into shareable CDS is still
evolving, and this project will help to identify drivers and barriers to implementation of infectious disease
screening recommendations. Involvement of multiple representative users during the design phase of CDS
development can enhance acceptability and usability of CDS.
Drs. Yun and Michel have developed a comprehensive plan for translating evidence-based recommendations
for infectious disease screening during the care of immigrant children into shareable CDS. They build upon a
previous collaboration to complete a similar task for refugee children. During this award period, they will apply
user-centered design to create CDS based upon the American Academy of Pediatrics’ immigrant health
screening recommendations and then confirm that this CDS meets the needs of diverse primary care providers
and immigrant families through user-tests. For this project they will draw upon a broad user base including
clinicians, immigrant families, and language services professionals in order to capture the functional
requirements for CDS from numerous viewpoints. This rigorous implementation development and testing will
support their planned submission of a follow up project to test the impact of this application on clinical
outcomes and to support dissemination of this CDS broadly.

Public health relevance
Project Narrative Children who move to the United States from other countries benefit from infectious disease screening. This study will use human factors research and user-centered design to develop an electronic health record-based tool to improve infectious disease screening adherence among primary care clinicians for immigrant children drawing upon the input of clinicians, immigrant families, and language service professionals to design an acceptable and usable tool. After the tool is developed, it will be tested it to ensure that it is acceptable to clinicians and that it meets the needs of immigrant families.